Receptor Usage and Regulation of the Immune Response in HSV Infection

Project Description:
Herpes simplex virus type I (HSV-1) infection is often asymptomatic or may produce recurrent lesions in and
around the mouth, commonly called “cold sores.” Ocular herpetic disease, typically caused by HSV-1 either
through primary infection or reactivation from the trigeminal ganglia (TG), can have serious sequelae, including
permanent corneal scarring and blindness. Herpes stromal keratitis (HSK) is one of the most common causes
of infectious blindness in the developed world, and worldwide produces over 40,000 new cases of severe
vision impairment or blindness each year. Interestingly, the majority of HSK tissue damage is thought to be
immune-mediated rather than resulting from direct lytic effects of the virus. Even after the virus has
successfully been cleared, high levels of inflammatory cytokines and chemokines, immune cell infiltrates, and
neovascularization persist. How HSV-1 infection of the eye leads to this chronic inflammatory syndrome is not
well understood. By studying cellular factors that influence the host immune response, we will delineate the
cascade of events that begin with a viral infection and end with chronic inflammation and vision loss. This
proposal represents a continuation of our studies examining cellular factors that are important for HSK using a
murine model. The studies proposed here will address the immunomodulatory functions of PILRA and HVEM
in Herpes Simplex Virus (HSV) Keratitis. By investigating how PILRA and HVEM contributes to HSK, we will
better understand the viral-host interactions inflammatory syndrome that persists in the absence of replicating
virus, providing a basis for therapeutic interventions for HSK.

Public health relevance
Public Health Relevance: Our specific aims are to identify the importance the immune-modulatory proteins PILRA and HVEM in herpes stromal keratitis (HSK). Understanding the role of these cellular receptors and how they contribute to the disease will provide insight for the development of novel therapeutics for the treatment of HSK, which is a frequent cause of corneal blindness in the US.